Contributions of Myeloid Metabolism to Diastolic Dysfunction

Thorp Project Summary Abstract
Diastolic dysfunction (DD) and Heart failure with Preserved Ejection Fraction (HFpEF) are
significant and hetetogenous causes of morbidity and mortality with few effective therapeutic
strategies. Increased understanding of HFpEF has been earmarked as a NIH research priority.
Two risk factors, fat and hypertension, are commonly found in cardiometabolic HFpEF patients,
and both independently associate with inflammation and DD. The extent of inflammation is a
critical determinant of the degree of cardiac fibrosis and myocardial stress that likely contributes
to impaired cardiac performance. As such, the resolution of inflmammation has the potential to
ameliorate myocardial pathophysiology. In this context, inflammatory immunometabolic
signaling has been linked with to the progression of disease, yet little is known with respect to
how immune metabolism regulates DD. This is particuarly true for myeloid cells and especially
the macrophage, in which immuonometabolic contriubtions to DD are either unknown or vague.
Our preliminary data point to signifcant mitochondrial stress in macrophages during DD. This is
an opportunity to combine improved basic understanding of basic cellular mechanisms with the
revealing on potential new metabolic therapeutic targets. In our first experimental Aim, we will
test the causal associations of myeloid lipid and mitochondrial metabolic pathways during
experimental DD. Aim II will elucidate cell-intrinsic immunometabolic macrophage signaling
networks that regulate pathways of inflammatory acceleration during DD-associated pathology.
Aim III will test the therapeutic proof of principle and clinical relevance of myeloid cell
metabolism during DD. Our Aims will leverage newly generated and cutting-edge experimental
tools and approaches. Taken together, these studies will provide new insight into the underlying
inflammatory mechanisms and therapeutic immune targets of DD and immunometabolic
signaling.

Public health relevance
Thorp Narrative Lay Due in significant part to limited therapeutic options and incomplete understanding of mechanisms of pathophysiology, diastolic dysfunction (DD) and Heart Failure with Preserved Ejection Fraction (HFpEF) encompasses approximately half of all heart failure cases. Our data implicate maladaptive metabolism of innate immune cells in the progression of DD during HFpEF. The studies outlined in this proposal are among the first to test the therapeutic proof of principle, mechanistic basis, and clinical relevance of immune metabolism during DD.